Mechanisms of spontaneous and vaccine mediated hepatitis C virus control to direct rational development of a novel HCV vaccine

Overall Project Summary
Hepatitis C virus (HCV) infects ~70 million people worldwide and is a major cause of hepatocellular carcinoma
and liver failure. Even with highly effective HCV treatment, recent data show that 80% of high-income countries
are not on target to meet the WHO goals of elimination of HCV. In most countries, the annual number of new
infections remains higher than the number cured by treatment. A vaccine for HCV should be possible because
25% of people resolve primary infection with effective anti-viral T cells and the generation of broadly neutralizing
antibodies (bNAbs). Recently, we have identified people who are repeatedly exposed to HCV with reinfection
and control of up to six distinct HCV infections, often of more than one HCV genotype. To date, one candidate
vaccine has been tested in an at-risk human population. This vaccine was designed to induce robust T cell
responses and was evaluated by proposal investigators for immunogenicity in healthy volunteers and for efficacy
in the prevention of HCV persistence in people at high risk of HCV infection. Although not protective against
chronic infection, vaccinated participants had significantly reduced mean peak HCV RNA compared to placebo
recipients. Our overarching hypothesis is that defining HCV-specific T cell and antibody mediated immunity in
effective control of HCV infection can be directly translated into more effective vaccine strategies. Therefore, we
plan an integrated analysis of T cell and B-cell/Ab mediated immunity alongside an assessment of viral antigen
sequences in resolved infection and vaccinees. This will inform the design and pre-clinical assessment of novel
vaccine strategies. In Project 1, CD4 and CD8 T cell responses will be compared between people who are
repeatedly exposed to and spontaneously control HCV and HCV clinical trial participants, both to define T cell
properties associated with HCV control, but also to identify the reasons for vaccine failure. NAbs also contribute
to successful control of repeated HCV exposure and work across several projects will identify and test novel
vaccine antigens and platforms with potential to induce anti-HCV bNAbs. Binding (Project 2) and structural
(Project 3) studies of bNAbs in complex with envelope proteins (E2 or E1E2) selected through a collaboration
between projects 2 and 4 will identify a panel of potential vaccine antigens with unique structural characteristics
that favor bNAb induction and maturation. Project 3 will develop nanoparticle (NP) and virus-like particle (VLP)-
based vaccines to present these E2 or E1E2 antigens and test them in mice. Project 5 will assess new T cell
immunogens in viral vectored vaccines, with viral vectored E2 or E1E2, NPs, or VLPs in mice, aiming to generate
both anti-E1E2 antibodies and the effective, genotype cross-reactive T cell responses defined in Project 1. We
will then test the two most successful vaccine candidates in non-human primates. The proposed integrative
research will provide a precise molecular description of infection events and the comprehensive characterization
of adaptive immune responses underlying effective HCV immune control, with new vaccine candidates assessed
in pre-clinical studies to identify the best vaccine antigens and strategy to advance to future human trials.

Public health relevance
Project Narrative Persistent HCV is a common cause of liver failure and death. There was limited effect of the only vaccine tested for prevention of HCV infection. We will define the successful immune responses observed in people infected with HCV many times who never become persistently infected and compare them to those seen in the only human vaccine efficacy trial and in vaccine models in order to design a more effective HCV vaccine.